Unlocking whole brain, layer-specific functional connectivity with 3D VAPER fMRI

ABSTRACT
The increased availability of ultra-high field scanners provides an opportunity to perform fMRI at sub-millimeter
spatial scales and enables in vivo probing of laminar function in the human brain. Investigations at this new
mesoscopic spatial scale in neuroscience not only advance our understanding of the cortical micro-circuitry in
vivo in health and disease, but also help bridge the gap between macroscopic (e.g., conventional fMRI, behavior)
and microscopic (e.g., extracellular recordings) measures of brain function. However, despite promising
potentials, critical barriers remain in achieving adequate sensitivity, specificity, accuracy, coverage at this scale.
Until recently, most layer-fMRI studies have been confined to one of the primary cortices using a task design
with a small brain coverage together with macro-vascular-contaminated sequence contrasts for functional
measurement and defining cortical layers roughly based on distortion mis-matched anatomical reference.
In this project proposal, we will develop a whole-brain layer-specific imaging sequence tool in humans, for
achieving fMRI at high resolution (£800 µm isotropic), high specificity (not being spatially biased with unspecific
vein signals as in BOLD), high sensitivity (robust measurement at layer-level resolution), high spatial accuracy
(layer fMRI analysis in native fMRI space to avoid blurring and errors arising from registration), whole brain
coverage, and eventually extending layer fMRI to more flexible connectivity-based experiment designs. We will
adapt two sequence methods, one is an integrated blood volume and perfusion (VAPER) contrast method to
improve layer fMRI specificity, and the other is a magnetization transfer (MT) weighted anatomical EPI imaging
technique to facilitate determination of cortical depth in native fMRI space. We will improve the pulse design of
the VAPER/MT preparation and incorporate them with a skipped-CAIPI 3D-EPI (segmented acquisition with
CAIPIRINHA sampling) acquisition, as a new method we will call VAPER/MT-3D-EPI. We will develop the
sequence and optimize its design for a whole-brain 0.8-mm isotropic imaging, and demonstrate its sensitivity
and specificity through measuring layer-dependent activity. We will use this new sequence to collect a whole-
brain submillimeter functional image dataset in humans at both resting state and during movie-watching,
establish the layer-specific functional connectivity analysis pipeline, and investigate the involvement of different
cortical layers in the maintenance of the brain networks. We will publicly share the data and analysis code to
facilitate development of layer fMRI methods and demonstrate VAPER/MT-3D-EPI as a user-friendly layer fMRI
tool for network neuroscience.

Public health relevance
NARRATIVE Investigations at cortical layer level in neuroscience not only advance our understanding of the cortical micro-circuitry in vivo in health and disease, but also help bridge the gap between macroscopic (e.g., conventional fMRI, behavior) and microscopic (e.g., extracellular recordings) measures of brain function. In this project, we will develop a whole-brain layer-specific imaging sequence tool in humans, for achieving fMRI at high resolution (£800 µm isotropic), high specificity (not being spatially biased with unspecific vein signals as in BOLD), high sensitivity (robust measurement at layer-level resolution), high spatial accuracy (layer fMRI analysis in native fMRI space to avoid blurring and errors arising from registration), whole brain coverage, and eventually extending layer fMRI to more flexible connectivity- based experiment designs.